Development Core

PROJECT SUMMARY/ABSTRACT
The declining numbers of biomedical scientists and a significant lack of diversity in the scientific
workforce are a grave problem that severely impacted the kidney, urology and hematology (KUH)
workforce, while these fields experienced major scientific advances. The KUH-ART proposes to create
a Professional Development Core (PDC) that will provide resources to recruit and nurture highly
effective KUH scientists not only by aggregating and curating pre-existing programs within the KUH
partner institutions, but by including new programs to expand the horizons of trainees and their mentors.
Novel programs will include the “Being a Leader” certificate course that will allow participants to master
being a leader, and the effective exercise of leadership as their natural self-expression, in real-time and
in any leadership situation. In addition, trainees will have access to the UCLA Anderson School of
Management Healthcare Specialization Courses and the Mentorship Training Program. In effect, the PDC
will be a well-designed, fully supported, well-executed program to fill the space in the pipeline between
early education and academic advancement. We plan to develop individualized, customized curricula
in the form of Individualized Trainee/Mentor Development Plans (ITMDP). The plan will focus on
honing the skills of both the trainee and the mentor that will directly impact the trainee’s development
and will be used for evaluation and feedback. We hypothesize that the KUH-ART PDC will provide the
resources needed for pipeline trainees to ensure that they acquire the knowledge and skills to
successfully traverse their individual research career paths towards independence. We propose the
following specific aims: (1) To develop the infrastructure, and implement KUH-ART trainee-specific
programs to ensure successful transition across all stages of professional development; (2) To develop
and implement programs to provide common knowledge set and skills to support all stages of
professional development; (3) To evaluate, monitor and provide feedback to trainees and mentors to
optimize professional development, based on creation of ITMDPs, and (4) to maximally link the
Professional Development and Networking cores for optimal success with the TL1 program. We are
confident that this integrated, comprehensive set of programs will foster a community of trainees
acquiring the necessary knowledge and skills to allow them to successfully navigate their academic
KUH career pathway.